Nonalcoholic Steatohepatittis Clinical Research Network (NASH CRN)

Nonalcoholic fatty liver disease (NAFLD) is a growing cause of end-stage liver disease. Despite many advances,
there remains an unmet need to better understand the variable clinical course of affected subjects, the factors
driving such variability and develop effective treatment to prevent cirrhosis due to nonalcoholic steatohepatitis
(NASH). The NIDDK NASH Clinical Research Network (CRN) has performed four clinical trials, numerous
ancillary studies and enrolled 3000+ subjects in to a prospective cohort database-2 study with protocol-mandated
follow up, bio-sample collection and adjudicated outcomes assessment; this cohort has been followed up to 10+
years and outcomes are beginning to be seen. In this competitive renewal application from the VCU adult clinical
center and the Emory University pediatric center, we will build on the gains from the current cycle by performing
studies with the following aims: (1) To actively participate in NASH CRN activities and recruit/retain adult and
pediatric subjects in ongoing and future consortium-wide and ancillary studies e.g. database-2 and STOP-
NAFLD. These studies will generate critically needed outcomes data needed for biomarker development, holistic
modeling of disease progression and to inform the design of long-term clinical trials. (2) To establish and lead
“The NAFLD Atlas (TNA)” to guide models of disease development and progression, identification of novel
biomarkers and Precision Medicine approaches for NASH. Here we provide a vision to integrate the clinical,
laboratory, genomic, transcriptomic and lipidomic data being obtained by the CRN with histological- and clinical-
outcomes data. This approach, analogous to the cancer genome atlas for cancers, will permit unprecedented
multi-dimensional analytic approaches to accelerate the identification of new diagnostic and prognostic markers,
new targets for pharmaceutical interventions and Precision Medicine approaches for the prevention and
treatment of NASH. The infrastructure required for data formatting, storage, integrity, analytics and visualization
for both CRN and the greater research community is outlined along with a viable “modular” funding model. Key
external collaborators with the required skills and experience have joined this effort. (3) To lead and perform a
NASH CRN-wide prospective, randomized, double-blind placebo-controlled clinical trial of Pioglitazone and
Vitamin E (rrr α-tocopherol, 800 IU/day) in those with NASH with bridging fibrosis (PIVENS II). The premise for
this trial includes the unmet need for therapies that prevent cirrhosis the driver of liver outcomes in NASH, the
available data to support a role for pioglitazone and vitamin E for NASH and their independent mechanisms of
action making them suitable for combination in a trial. The primary endpoint is the proportion of subjects who
progress to cirrhosis; the trial population is selected based on their high risk of such progression and thus
likelihood of benefit. Together, the proposed studies will further all of the objectives of RFA-DK-18-505 for
continuation of the NASH CRN by participation in ongoing CRN activities, creation of the NAFLD atlas for the
entire research community and delivery of therapeutic options to prevent cirrhosis in those at highest risk.

Public health relevance
The aims of this proposal are to actively participate in CRN activities, create the NAFLD atlas which will integrate multiple “Omics” data with metadata and link these to outcomes and by perform a clinical trial to test the ability of a combination of pioglitazone and vitamin E to prevent cirrhosis in those with NASH and bridging fibrosis.